Validation of Small-Vessel Disease Neuroimaging Biomarkers in Cerebral Amyloid Angiopathy-Related Cognitive Decline

PROJECT SUMMARY/ABSTRACT
Vascular cognitive impairment (VCI) due to cerebral small vessel disease (SVD) is now recognized as a key
public health issue evidenced by the 2016 NIH Alzheimer's Disease-Related Dementias Summit
recommendations. Although individual neuroimaging biomarkers such as cerebral microbleeds (MB) or white
matter hyperintensities (WMH) are often used in the diagnosis and monitoring of VCI due to small vessel
disease, no single neuroimaging biomarker has emerged as a valid surrogate marker for small vessel VCI
trials. This may be because it remains uncertain if any single biomarker more strongly impacts cognition
compared to the others or if there is a cumulative effect of these lesions. Recent emerging evidence strongly
suggests that new diffusion tensor imaging (DTI) measures can reliably capture the cumulative effect of
different SVD lesions in patients with various forms small vessel VCI. These DTI-based biomarkers are thus
highly promising candidate biomarkers for VCI trials. The purpose of this proposal is to use the well-
characterized small vessel disease cerebral amyloid angiopathy (CAA) to validate DTI as a SVD biomarker by
determining 1) DTI's association with cognitive impairment independent of other imaging parameters, and 2)
DTI's underlying biologic mechanism. CAA is an age-related SVD that is a common cause of small vessel VCI
and is characterized by progressive deposition of β-amyloid (Aβ) in the wall of cortical and leptomeningeal
small arteries. Neuropathological evidence suggests that CAA contributes to dementia independent of other
age-related neuropathologies, including Alzheimer's disease (AD). All of the individual biomarkers of small
vessel VCI are seen in CAA, including MB and WMH. Additionally, autopsy studies suggest that cerebral
microinfarctions (CMI), an important feature of small vessel VCI, are common in CAA. CAA is also associated
with DTI changes that appear to correlate with clinically important measures like executive function and
processing speed. CAA thus represents an ideal model of small vessel VCI. The current proposal first aims to
show that DTI-based biomarkers strongly track cognitive change in CAA. Secondly, it aims to establish the
histopathologic basis of these biomarkers in order to produce a biologically validated biomarker for use in
clinical trials in CAA and small vessel VCI. Successful conclusion of the proposed aims has high potential for
elucidating the mechanistic basis of DTI abnormalities in CAA and would result in a trial-ready DTI-based
biomarker for potential candidate treatments in small vessel VCI. Insights gained from these studies will also
be critical in defining the tissue injury mechanisms to be targeted when selecting future candidate treatments
for small vessel VCI. The proposed analyses aim to build a complete bridge from neurologic function to in vivo
DTI, ex vivo DTI, and ultimately to gold-standard neuropathology. While these studies involve CAA, we
anticipate that this DTI-based biomarker would be broadly applicable to many types of small vessel VCI seen
in the clinic.

Public health relevance
PROJECT NARRATIVE Cognitive impairment due to dysfunction of small blood vessels in the brain is now recognized as a key public health issue. MRI has proven to be a powerful tool for detecting injury caused by diseases of these small blood vessels, a very frequent cause of cognitive impairment and dementia. However, while we are able to detect different types of vascular brain injury with this technique, our inability to capture the cumulative effect of all these vascular injuries in addition to our very limited understanding of what MRI is measuring, makes it difficult to apply this tool to identify effective treatments. We therefore propose to test a new candidate MRI measure that captures cumulative vascular brain injury in patients with the small blood vessel disease cerebral amyloid angiopathy. We will also perform MRI on brains obtained at autopsy from patients, and then systematically examine the brains by microscope to determine the basis of their MRI changes. These studies will create a strong foundation both for understanding the mechanisms by which small blood vessel diseases interfere with the brain and for incorporating MRI into efficient, well-designed trials of promising treatments for the growing threat of age-related cognitive impairment.